Role of the Prefrontal Cortex in the Control of Arousal States

PROJECT SUMMARY/ABSTRACT
Advances in the field of anesthesiology have made the administration and maintenance of general anesthesia
a relatively safe and well-controlled procedure. In contrast, emergence from anesthesia is passive and a poorly
controlled process with an unclear neurobiology. We recently showed that a subanesthetic dose of ketamine
during exposure to isoflurane counterintuitively accelerated the recovery from anesthesia, increased levels of
acetylcholine in prefrontal cortex (PFC), and restored PFC connectivity to posterior cortex. Subsequently, we
reported that cholinergic stimulation of PFC by local carbachol infusion restored wakefulness despite
continuous exposure to clinically-relevant concentrations of general anesthesia. These data suggest that
cholinergic processes in PFC control behavioral arousal and can be harnessed to accelerate recovery from
anesthesia. However, mechanistic understanding is lacking. Our long-term goal is to understand the
neurobiological processes that mediate recovery from physiologic, pharmacologic, and pathologic states of
unconsciousness. The overall objective of the proposed studies is to identify the neural circuits through which
PFC stimulation by local carbachol infusion or systemic delivery of subanesthetic ketamine produces
accelerated recovery from general anesthesia. The central hypothesis, supported by our preliminary data, is
that the reciprocal circuit of PFC and basal forebrain regulates behavioral arousal, and that subanesthetic
ketamine co-opts this pathway to hasten recovery from general anesthesia. The rationale for the proposed
research is that it will yield fundamental mechanistic knowledge of the neural pathways involved in arousal and
recovery of consciousness. To test our hypothesis, we will pursue the following three specific aims and
approaches in a rat model: 1) Demonstrate that PFC acts through basal forebrain to control behavioral
arousal - we will stimulate PFC by local carbachol infusion with or without concurrent tetrodotoxin (TTX)-
mediated inactivation of basal forebrain or selective chemogenetic inhibition of basal forebrain cholinergic and
GABAergic neurons, which have been implicated in wakefulness, 2) Determine the role of basal forebrain
projections to PFC in controlling behavioral arousal - we will chemogenetically stimulate basal forebrain
cholinergic or GABAergic neurons, with or without concurrent TTX-mediated PFC inactivation. To confirm a
causal role for acetylcholine in PFC in ketamine-induced accelerated recovery from anesthesia, we will infuse
cholinergic antagonists into PFC during systemic delivery of subanesthetic ketamine, and 3) Determine the
role of cortical connectivity and complexity in behavioral arousal - we will use carbachol/ketamine-
induced recovery from anesthesia as a model system to dissect the state vs. anesthetic drug effects on
functional cortical connectivity and spatiotemporal complexity. The proposed research is significant because
we expect it to provide fundamental mechanistic understanding of the role of the PFC in behavioral arousal
and recovery from anesthesia, with translational implications.

Public health relevance
PROJECT NARRATIVE Public Health Relevance Statement: This research proposal is relevant to public health and the mission of the National Institutes of Health because it aims to understand the neurobiological mechanisms of behavioral arousal and the recovery of consciousness, which can ultimately have a positive impact on the fields of anesthesiology (recovery from general anesthesia) and neurology (recovery from disorders of consciousness).